Project 2: Early crosstalk between HTLV-1 infected T cells and bone microenvironment

PROJECT SUMMARY/ABSTRACT - PROJECT 2: Early crosstalk between HTLV-1 infected T cells and
bone microenvironment
Adult T cell leukemia/lymphoma (ATLL), a malignancy of HTLV-1 infected T cells, stands out from other acute
leukemias in its frequent association with hypercalcemia and propensity to form localized lymphomatous
osteolytic lesions. Osteoclasts are directly responsible for the degradation of bone that releases calcium. In the
previous funding period, we demonstrated that patient derived ATLL cells (ATLL-PDX) and a subset of HTLV-
infected T cell lines release small extracellular vesicles (sEV) with powerful osteoclastogenic effects in vitro and
in vivo. We have found that the proteome of osteolytic sEV is enriched for metabolic pathways; in concert, the
transcriptional signature of osteoclasts exposed to these sEV reflect a metabolic shift, demonstrating enhanced
glycolysis and hypoxia, features of a tumorigenic microenvironment. We hypothesize that crosstalk between
HTLV+T and osteoclasts provides a tumorigenic microenvironment impacting HTLV+T cell fate. Previous
work, including our own, has focused primarily on the ability of transformed ATLL cells to enhance the formation
and activation of osteoclasts. This proposal’s focus on HTLV-1 infected T cells prior to transformation and the
feedback on osteoclasts and other cells in bone, is novel. Aim 1: Define impact of the bone microenvironment
on HTLV-1 infected T cells via Notch and TGFβ. In this aim, we examine the signals from bone, resulting from
crosstalk with HTLV+T, that impact the fate of HTLV+T cells. To do this, we will profile gene expression and the
epigenetic state of HTLV+T cells residing in bone from our mouse model, compared to extraskeletal site. Aim
2: Define the role of osteoclasts in remodeling of the bone microenvironment by HTLV-1 infected T cells and
their sEV. We will implant HTLV+T or their sEV into bones of mice, with or without osteoclast blockade, and
perform detailed analysis of bone tissue by morphological and molecular analysis. We will also determine the
role of serum amyloid A, released by OC, and mir155 and mir21 present in osteolytic sEV. The successful
completion of this project will provide detailed information about cellular and molecular interactions that may be
therapeutically targeted to reduce the transition to ATLL or used to identify risks for progression.

Public health relevance
PROJECT NARRATIVE - PROJECT 2 T cells infected by HTLV-1 sometimes become malignant, but factors causing the transformation are not well-understood. We have found that the infected T cells have very strong interactions with the cells that remove bone, osteoclasts. Here we study this interaction to determine how it changes the behavior of the T cells in ways that favor malignancy.